PROTEIN STRUCTURE--ENZYME ACTION AND CONTROL

(1) Nucleotide analogs have been introduced as tructural probes into active sites of dodecameric glutamine synthetase from E. coli. Various analogs of ATP that are substituted at the 6- or 8-position of the purine ring have been further modified with spectrophotometric and fluorometric probes or an electron dense Pt(II) marker. Fluorescence energy transfer measurements were made with enzyme derivatives containing 1 or 2 eq of fluorescent nucleotide donor per dodecamer and ADP or acceptor analogs at the remaining active sites. Energy transfer was found to be from a single donor to 2 or 3 acceptors on adjacent subunits. The calculated distance between equidistant active-site probes on heterologously bonded subunits within the same ring is 56-61 Angstroms. Thus, active sites are away from the 6-fold axis of symmetry toward the outer edges of the dodecamer and are located greater than 30 Angstroms from the plane separating the hexagonal rings. The same fluorescent enzyme derivatives were used also to study the kinetics of zinc-induced face-to-face aggregation of enzyme dodecamers along the 6-fold axes of symmetry. (2) Bovine brain glutamine synthetase has 2 essential divalent cation sites/subunit--a structural site and a higher affinity nucleotide-metal ion site which can not be filled until the first site is occupied by Mn(II) or Mg(II). Chloride ions produce structural perturbations that may be physiologically important. (3) Calorimetric measurements of active-site ligand binding to E. coli glutamine synthetase continue. (4) Studies on th mercurial-promoted release of zinc from E. coli aspartate transcarbamoylate (ATCase) have been completed. Studies on the rebinding of zinc ions to isolated regulatory subunits of this enzyme are in progress. The results relate to changes in catalytic and regulatory chain interactions in ATCase molecules responsible for the allosteric properties of this enzyme and to mechanisms of dissociation and assembly of this enzyme.